Applied IPV Measurement (AIM) Shortcourse

Abstract
Homicide, often at the hands of intimate partners, is a leading cause of pregnancy-related death.
Intimate partner violence (IPV) is a widespread and serious public health problem. Globally, 30% of ever-
partnered women experience physical or sexual IPV, and over one third of female homicides are perpetrated
by intimate partners. Significant evidence demonstrates that IPV is a preventable cause of maternal mortality,
and poor health before, during, and after pregnancy, including severe maternal morbidity, especially for
populations that are disproportionately affected by maternal mortality and severe morbidity. The evidence base
on IPV has yet to translate evidence into effective interventions to improve maternal health and safety and
promote health equity. A core competency for maternal health researchers is understanding how to best
measure IPV and conduct IPV-related research in accordance with ethical protections specific to this topic.
These skills are critical building blocks to integrate IPV concepts within clinical, epidemiological, and
intervention research and practice in maternal health. Yet to date, dedicated IPV-related coursework in health-
related graduate and professional programs is quite limited. IPV is often included only peripherally within
coursework, and does not cover the nuances of measurement across populations, necessary ethical
protections, and importantly, the culturally-specific assessments and interventions necessary for successful
implementation and impact to achieve health equity. IPV-related training is thus an actionable gap in our
national ability to understand and address IPV as a threat to maternal health and health equity. Our
experienced, multidisciplinary team thus proposes a 2-year training project to: 1) develop an applied
educational curriculum to advance IPV measurement and research skills for diverse populations, 2) pilot and
implement the curriculum through an online accelerated short course within the Johns Hopkins University
Institute series, and 3) accelerate IPV research skills application by fostering community among trainees, and
providing ongoing mentoring and technical support as they build and apply their new skills. Our project fills a
critical gap in available training and accelerates progress on national goals of improved maternal health and
pregnancy outcomes through equipping the clinical and research workforce with specific skills and knowledge
necessary to integrate IPV-related experiences within maternal health research. The training will accelerate
the quality and impact of IPV-related clinical and intervention-related maternal health research for populations
in greatest need. In doing so, we advance national capacity to mitigate preventable maternal mortality,
decrease severe maternal morbidity, and promote health equity.

Public health relevance
Narrative The study advances the priorities of the NIH-wide IMPROVE initiative, by building skills to address IPV as a preventable cause of maternal death and poor health before, during, and after delivery, and disparities therein (e.g. race/ethnicity, life course stages, and social standing). Results will accelerate the quality and impact of clinical and intervention-related IPV research for populations in greatest need, contributing to our national ability to ensure women’s health and safety and promote health equity.